Translational Training Program in Pulmonary Biology and Medicine

SUMMARY/ABSTRACT
This competitive renewal occurs as our T32 Translational Training Program in Pulmonary Biology and
Medicine enters its thirty-fifth year of training researchers, physician-scientists, and visionary leaders. The
Division of Pulmonary, Allergy and Critical Care Medicine (PACCM) provides an outstanding training
environment and mentorship pool with a critical mass of collaborative basic, translational, and clinical
researchers in pulmonary biology and medicine led by internationally recognized scientists. Our goal is to
train the next generation of academic leaders in pulmonary medicine, and our program is designed to provide
outstanding education and cutting-edge research training with a comprehensive, structured, and individualized
career development approach. Our T32 will leverage the expertise and commitment of our diverse faculty to
ensure comprehensive training across the spectrum of pulmonary diseases using innovative technology,
computational skill, extensive patient cohorts, databases, and biorepositories to impact lung health and train
future pulmonary scientists. With eight postdoctoral trainee slots, our T32 places a significant emphasis on
training physician-scientists as well as PhD scientists over a two- to three-year training period. The research
training is a structured milestone-driven program that includes: a three-day, off-campus fellows research
retreat; translational core competencies; academic survival skills series; diversity, equity, and inclusion
training; optional month-long exposures to regulatory activities and drug development at Pitt start-ups; F/K-
level and K-to-R grant workshops; a successful grant review program; academic coaching; and a rigorous
program in responsible conduct of research. Our training plan is structured around individualized
development plans that emphasize quantifiable outcomes (publications, career development awards,
completion of didactic courses and graduate programs, transition to research and academic careers). The
next generation of academic leaders in Pulmonary Medicine needs to have access to skills in evolving
technologies at the bench, sophisticated computation and ‘omics approaches, large patient cohorts and data
analytics, and integration of social determinants of health. Our renewal offers several new initiatives including
emphasizing the cross-cutting themes in lung diseases of aging, health services and disparities, microbiome and
infections, and immunology and inflammation. Other initiatives include dedicated statistical training, expanded
training and collaborations in advanced computational and systems biology approaches, access to novel
lung tissue modeling techniques, career coaching, and a diversity and inclusion curriculum. We have the
trainee pool, leadership, advisory boards, training faculty, and infrastructure to build on an already rich and
successful translational training program and ensure continued development of the next generation of
biomedical researchers in pulmonary disease.

Public health relevance
NARRATIVE The long history of training success within the Division of PACCM at the University of Pittsburgh is now invigorated with new leadership, has a focus on fundamental biological themes and translational science, and is characterized by diverse trainees who continue to publish novel science, attain fellowship and career development awards, and transition to independent research careers. The success of this T32 will produce a new generation of scientists with the training, creativity, and resources tobe future leaders in the field of Pulmonary Biology and Medicine.